The Alliance NCTN Biorepository and Biospecimen Resource

PROJECT SUMMARY/ABSTRACT
The NCTN's Alliance for Clinical Trials in Oncology (Alliance) and its associated biorepositories represent
an unequaled resource of expertise, institutional infrastructure, and high quality, densely annotated patient
biospecimens collected from several decades of cancer therapeutic trials. The scientific mission of the
Alliance Biorepository and Biospecimen Resource (ABBR) is to support the activities of the Alliance, the
NCTN, and the broader cancer research community through four specific aims, which are: 1) To
prospectively support Alliance and NCTN-wide clinical cancer trials with respect to biospecimen
procurement, tracking, processing, quality assurance, storage, and distribution. The ABBR implements a
number of innovative approaches to streamline biospecimen collection and support the collection of novel
biospecimen types for genomic, proteomic, immunoncology, and `liquid biopsy' biomarker studies in the
context of therapeutic trials; 2) To provide a resource of high quality, densely annotated biospecimens for
secondary correlative science studies directed toward biomarker validation with high clinical impact. The
ABBR cooperates with other NCTN biorepositories, the NCTN Biospecimen `Front Door Service', and the
NCTN Navigator tool to provide inventories of biospecimens that may be suitable for secondary correlative
science studies proposed both within the NCTN groups as well as the broader cancer research community.
It also works with other NCTN members and NCI to create an efficient and transparent process for
reviewing, approving, and executing such requests so as to speed the translation of candidate biomarkers
to cancer diagnostics with clinical utility; 3) To provide scientific leadership to the NCTN biobanking
enterprise, by active participation in the NCTN Group Banking Committee (GBC). The ABBR will continue
its outstanding commitment to harmonizing and improving biobanking Best Practices by active participation
in GBC meetings, subcommittees activities, and work products, and; 4) To provide expertise and
infrastructure support for biobanking efforts aligned with and beyond the NCTN, including the Cancer and
Immune Monitoring Analysis Centers (CIMACs) and the Community Oncology Research Program
(NCORP). Having created a federated infrastructure of biorepository sites and a unifying informatics
platform for tracking biospecimens across them, the ABBR continues to be uniquely poised to collaborate
with other NCI programs, whenever biorepository or biospecimen resources are required for specific
translational cancer research efforts.

Public health relevance
PROJECT NARRATIVE The mission of the Alliance Biorepository and Biospecimen Resource (ABBR) is to safeguard and facilitate the use of patient tissue and fluid biospecimens for practice changing cancer research. The ABBR helps to collect, process, and store biospecimens from patients enrolled on NCTN Alliance clinical trials. The ABBR distributes biospecimens for biomarker studies associated with Alliance clinical trials and for secondary studies proposed by the broader cancer research community. Members of the ABBR work with the NCTN and other NCI research networks, contributing scientific leadership to maximize the scientific impact of NCI biospecimen resources. Encompassing multi-PI, multi-institutional pathology and biobanking expertise and hundreds of thousands of high quality, densely annotated biospecimens from several decades of clinical trials, the ABBR represents an unequaled academic resource for translational cancer research.